Upper Midwest Summit for Reproductive Science

PROJECT SUMMARY
Reproductive health underpins overall health and thus research in reproductive science and medicine
is essential. This requires a steady pipeline of trained scientists and clinicians, which can be challenging
given the relatively small size of the field. Professional opportunities outside the laboratory and
classroom are essential to providing our trainees with important scientific, leadership, and career
development experiences. Since 2008, Northwestern and other institutions in Illinois, including the
University of Illinois Urbana Champaign (UIUC), have hosted a biannual meeting on a rotating basis
entitled the Illinois Symposium for Reproductive Science (ISRS). Given the strengths of our collective
focus on reproductive science, our extensive trainee community, as well as our established institutional
infrastructures, our goal is to now expand this event to include five states and 16 institutions across the
Upper Midwest region. This application seeks funds to support the Upper Midwest Summit for
Reproductive Science. This conference will be hosted by Northwestern and the University of Illinois
Urbana Champaign in alternate years. A hallmark of this event is that it is largely organized and
coordinated by trainees, providing valuable leadership and professional development experience. The
trainee planning committee will be responsible for identifying themes and speakers, hosting and
chaperoning speakers, acting as session moderators, and working the registration table. The event will
be held over a period of a day and a half and will consist of a variety of presentation formats. Dedicated
poster sessions throughout the meeting allow participants to present their research, receive
constructive feedback, and engage in constructive dialogue other attendees. Panel sessions and a
career roundtable lunch will enhance the program by moving beyond the bench to discuss topics such
as innovation, advocacy, and communication. There will also be an invited keynote speaker, who will
be a luminary in the field, as well as an alumni speaker who will be someone who participated in the
conference as a trainee and now has a successful career in our discipline. Sessions will be organized
by topics and invited speakers and trainees will deliver oral presentations at this time. Throughout the
conference there will be many opportunities for trainees to network with each other and the conference
will be an annual opportunity for trainees to facilitate interaction among potential future lab mates, PIs,
and collaborators. To further enhance the trainee experience, both institutions have committed to
provide funds for trainee research awards for outstanding oral platforms and poster presentations.
Priority will be given to individuals who are underrepresented in science to maximize broad participation
of diverse speakers and trainees. Together we will leverage our collective institutional strengths to
maintain the Upper Midwest Region as a preeminent nationwide leader in this critical research field.

Public health relevance
PROJECT RELEVANCE Reproductive science and medicine encompasses the study of endocrinology, gonad development, gametogenesis and embryogenesis, and reproductive tract biology and research in this area has implications for fertility, contraception, pregnancy, fetal origins of adult disease, transgenerational epigenetic inheritance, aging, cancers, infectious diseases, and more. This application will fund the Upper Midwest Summit for Reproductive Science (UMSRS), which will coalesce reproductive science and medicine research across 16 institutions in five states in the Upper Midwest region (Illinois, Indiana, Kentucky, Michigan, and Wisconsin). UMSRS will showcase cutting-edge research in our discipline and unify regional institutions to expand collaborative networks while providing trainees with valuable professional development and leadership opportunities.